Veverimer to decrease net acid excretion and bone resorption in adults with osteopenia: a dose-finding randomized controlled trial

PROJECT SUMMARY
Starting in mid-life, bone resorption rises and exceeds bone formation – a process that leads to progressive loss
of bone mass, destruction of bone architecture, and ultimately an increased risk of fracture later in life. Acid-
producing diets, such as the modern Western diet, have been implicated as contributors to increased bone
resorption in mid-life and older adults. Younger adults are able to excrete the acid produced from the diet in their
urine but in mid-life and thereafter, the kidney loses the capacity to quantitatively excrete the daily acid load due
to age-related declines in both glomerular filtration rate and the tubular capacity to excrete acid. Through the
release of bone alkali as an acid buffer, bone helps preserve systemic neutrality, but at the expense of greater
bone resorption, bone loss, and an increased fracture risk. Adults with osteopenia who consume acid-producing
diets are at particularly high risk of progressing to osteoporosis. Evidence from our group and others indicates
that neutralizing excess acid with alkali therapy, such as potassium or sodium bicarbonate, reverses these
adverse bone effects. However, alkali treatment poses several challenges: it requires frequent and inconvenient
dosing schedules, gastrointestinal discomfort, and a substantial load of sodium or potassium which can
aggravate hypertension or risk hyperkalemia. Veverimer, a non-absorbable polymer that binds hydrochloric acid
in the intestine and excretes it in stool, offers a novel alternative to reversing the adverse effect of excess dietary
acid on bone. To date, veverimer in doses up to 9 g/d has mainly been tested in adults with advanced chronic
kidney disease and with metabolic acidosis. In those trials, veverimer corrected metabolic acidosis by 4 weeks
of treatment but bone outcomes have never been assessed. Veverimer was well tolerated without altering
potassium or sodium metabolism. We propose a Phase 1 randomized controlled trial in adults 50 years and older
with osteopenia who consume acid-producing diets (based on a 24-hr urinary net acid excretion [NAE] level of
≥15 mmol/d). Lower doses of veverimer were selected as our osteopenic adults will have minimal impairments
in kidney function. Participants will be randomized to treatment for 12 weeks with placebo or veverimer in a dose
of 3 g/d or 6 g/d to meet the following aims: Aim 1: Identify the extent to which each dose of veverimer (vs.
placebo) reduces 24-hr urinary NAE. Aim 2: Describe the safety of veverimer as indicated by changes in serum
HCO3-. Aim 3: Assess the variability in change in bone resorption (serum C-telopeptide level). Aim 4: Assess
the variability in change in bone formation (serum procollagen type I N-terminal propeptide ) in response to the
different doses of veverimer. This information is needed to estimate the sample size of a future trial. Identifying
the dose of veverimer that safely lowers NAE to the optimal level is an essential first step in the process of
assessing whether veverimer is a promising approach to reducing bone loss attributable to acid-producing diets.
This Phase 1 dose-finding study will provide the information needed to design a clinical trial to determine the
effect of veverimer on bone resorption, bone mass, and ultimately fracture risk in adults at risk for osteoporosis.

Public health relevance
PROJECT NARRATIVE Data from our laboratory and others demonstrate that reducing the acid-producing load of commonly consumed diets in the US can in turn decrease the breakdown of bone that starts in mid-life and thereafter. However, currently proposed methods to achieve this acid-base balance are burdensome and poorly tolerated. This randomized, controlled clinical trial will be the first study to determine whether a new non-absorbable acid binder, veverimer, will reinstate acid-base balance and reduce bone resorption in adults with osteopenia.